Comparative analysis between patient-derived models of pancreatic ductal adenocarcinomas and matched tumor specimens

PROJECT SUMMARY
Pancreatic ductal adenocarcinoma (PDA) is a lethal cancer, with a 5-year survival rate of < 10%; it is predicted
to become the 2nd leading cause of cancer-related deaths in the US by 2020. Somatic alterations of four driver
genes (KRAS, TP53, CDKN2A, and SMAD4) are common among many cases of PDA; however, PDA can be
phenotypically categorized into multiple neoplastic subtypes, each with myriad types of stroma and anti-tumor
immunity. Only incremental clinical advances have been made in the treatment of PDA, potentially due to the
paucity of well-annotated and validated patient-derived models of pancreatic cancer available to the research
community. As a first step to translating the use of patient-derived models of cancer (PDMCs), we must identify
the strengths and limitations of each type of PDMC, including whether PDMCs mirror genetic and biologic
characteristics of the human, parent tumor. Herein, we propose a multi-institutional project designed to extend
our existing library of PDA PDMCs and depict which model(s) best represent specific aspects of their parent
tumors. PDMCs that capture an inter-tumor heterogeneity and can maintain pro-oncogenic regulatory pathways
are critically needed to better enhance current therapies and identify novel therapeutic strategies. We are
currently collecting PDA specimens and generating conditionally re-programmed cells (CRC), organoids (ORG),
and patient-derived xenografts (PDX) through the Oregon Pancreas Tissue Registry and from a targeted therapy
(i.e., PARP inhibitor-based) clinical trial. The PDMCs generated have well-annotated clinical outcomes and drug
response data. Here, we will systematically and thoroughly profile matched PDMCs to determine the significance
of key molecular networks (including KRAS, MYC, DDR, HuR, and inflammation) and phenotypic subpopulations
that best match their respective tumors from patients. We will also build more complex PDMCs by adding
elements of the parent tumor microenvironment that can restore phenotypes absent in simple PDMCs.
Complementary drug sensitivity studies will be tested in both simple and complex PDMCs as another metric of
their relatedness to the parent tumor and patient responses. To perform this work, we have assembled a multi-
disciplinary team with expertise in clinical oncology, specimen collection/processing, pathology, cancer model
generation, tumor microenvironment, computational biology, RNA biology, DNA repair, and database
management. Work will be performed in three specific aims: Aim 1, generate and validate PDMCs; determine if
key PDA signaling pathways are conserved with the matched parent tumor; Aim 2, identify PDMCs from clinically
tracked specimens that best predict drug responses in patients; identify and target key pathways of resistance;
Aim 3: identify signaling pathways and drug responses that are lost in simple PDMCs but that can be restored
by adding known elements of the parent tumor (e.g., stromal mesenchymal, endothelial and immune cells). An
overarching deliverable of this study will be to share well-characterized, validated PDMCs and molecular insights
into PDA biology and drug responses with the pancreatic cancer community.

Public health relevance
PROJECT NARRATIVE Pancreatic adenocarcinoma is one of the most lethal of human cancers and is predicted to become the second leading cause of cancer related deaths in the United States by 2020. Traditional chemotherapy is currently the only recommended treatment, and the 5-year survival rate for PDA is less than 10%. There is therefore a critical need to generate robust patient-derived laboratory models of PDA that can be used to increase our understanding of the biology of this deadly disease and to identify better therapeutic strategies for improving patient outcomes.